Creating Opportunities for Underrepresented Researchers to Achieve Growth and Excellence (COURAGE)

PROJECT SUMMARY/ABSTRACT
Obesity, nutrition, and diabetes research in the United States suffers from a lack of diversity in the research
community, as underrepresented (UR) investigators face more challenges than their majority counterparts and
leave academic research positions at a higher rate. We propose a comprehensive longitudinal career
advancement program, Creating Opportunities for Underrepresented Researchers to Achieve Growth and
Excellence (COURAGE), to provide skill-building, leadership development, hands-on mentored experience in
manuscript writing and grant preparation, and multi-level mentoring to support UR researchers in obesity,
nutrition, and diabetes. Two cohorts of 10 COURAGE Scholars will be recruited to participate in a 3+ year
program. The first two years will consist of group and individualized curricula, mentored research and writing
experiences, execution of the pilot project, and multi-level mentoring. Year 3 onward will consist of ongoing
mentoring from faculty and program leadership, continued engagement with COURAGE peers, and access to
program resources. The MPIs leading COURAGE are accomplished researchers who bring complementary
expertise in implementing programs to advance early-career researchers from UR backgrounds. Dr. Morone
led a successful UR career development program at the University of Pittsburg and is now MPI of an NIH U01
testing this year-long intervention at sites around the country. Her expertise in implementing skill-building
curricula makes her ideally suited to lead Aim 1, to provide a longitudinal program of skill-building to promote
success in obesity, nutrition, and diabetes research. Dr. Stanley has extensive experience mentoring fellows
and junior faculty, and she leads the successful pilot and feasibility program for the Nutrition Obesity Research
Center at Harvard. She is thus ideally suited to lead Aim 2, to mentor COURAGE Scholars in the successful
completion of pilot projects and application for an NIH grant. Dr. Stanford is an accomplished national leader
and advocate for diversity within academic medicine; she is ideally suited to lead Aim 3, to prepare Scholars
for academic leadership. Scholars will build a mentorship network that includes their peers, the MPIs, the
Program Director, Dr. Mattei, the COURAGE epidemiologist Dr. Fox, and COURAGE faculty mentors. Scholars
will complete the program with key deliverables including at least one submitted manuscript, a completed pilot
project, and a submitted grant application. This program is a collaboration between multiple academic
institutions: Massachusetts General Hospital, Harvard University, Boston Medical Center/Boston University,
Morehouse School of Medicine, and University of Puerto Rico Medical Sciences Campus. COURAGE program
leadership and mentors represent all these institutions, and Scholars will be recruited representing each of
these institutions. At the completion of COURAGE, Scholars will have enhanced academic and leadership
skills, mentored research and writing experience with completed manuscript(s) and grant submissions, and a
robust mentoring network that will continue supporting them as they move forward in their careers.

Public health relevance
PROJECT NARRATIVE Researchers from underrepresented backgrounds face significant challenges throughout their careers and leave academic research at a higher rate than majority peers. Our comprehensive career development program, COURAGE, will serve two cohorts of 10 researchers in obesity, nutrition, and diabetes who are from underrepresented backgrounds, providing skill building and leadership training, hands-on guidance in manuscript and grant writing, and multi-level mentoring to support career advancement and continued success in academic research.